The Neuronal Underpinnings of Non-invasive Laminar fMRI

The six layers of cortex form distinct computational units that together govern the information flow and processing required for complex behavior. Hence, unravelling the brain's computational strategies requires understanding the layer-specific organization of the neocortex. Until recently, layer-resolved recordings have been confined to animal models, ignoring specific properties of the human brain and limiting our ability to study uniquely human functions such as language. The unprecedented opportunity to combine laminar electrophysiology recordings in humans with High-field fMRI in the same human subjects could close this gap; however, inherent vascular artifacts prevent a straightforward depth-resolved interpretation of the BOLD signal. To disentangle vascular from neuronal processes, we propose to develop a neurovascular coupling model by combining the laminar electrophysiology data with laminar fMRI in the same human subjects. To this end, we will exploit a unique opportunity to record ground truth, layer-resolved neuronal activity in epilepsy patients. We hypothesize that such a model - validated using data from patients and controls and multiple tasks - will resolve layer-specific neuronal activation from fMRI responses and will be applicable to the general population, across tasks, and cortical areas — without the need for additional electrophysiological data. 1

Public health relevance
Understanding the neural basis of cognitive processes in humans, such as perception, decision-making and language, requires, non-invasive imaging methods that can capture cortical processes at ultra-high resolutions. High field functional magnetic resonance imaging (fMRI) is poised to achieve this, however, understanding the relationship between fMRI and neural activity at this spatial scale in humans remains challenging. We propose an innovative approach that combines cutting-edge high-resolution fMRI with invasive electrophysiological data from the same human subjects. This will in turn permit a generative biophysical fMRI signal model. In doing so, we will improve our capacity to study human cognition and mechanisms of neocortical dysfunctions leading to neurologic and psychiatric disorders.